Administrative Core

Abstract (Administrative Core) The Administrative Core will oversee coordination and integration of all U19 Program functions; guide and facilitate interactions between the Project and Core leaders, Principal Investigators, and research staff; provide rigorous and regular fiscal oversight of the research projects and cores; ensure that the U19 TeamBCP maximizes the utilization of existing and established resources; and facilitate data, technology and information sharing and collaboration with key BRAIN Initiative stakeholders and the greater neuroscience research community. The core will be lead by our Team Directors, Rui Costa and Tom Jessell, and have an Internal Advisory Committee, a Data Science management sub-committee, an External Advisory Committee and a dedicated staff Program Manager. The core will a) provide overall coordination and support for the TeamBCP U19 research activities, b) foster growth of the Motor Control research within and beyond our research team, c) oversee and ensure resource dissemination and outreach, and d) fiscal and administrative management of cores and research projects. The Internal Advisory Committee will meet monthly to discuss all administrative issues and to provide scientific direction for the program. Drs. Costa and Jessell will co- chair these meetings. The needs, usage and effectiveness of the Cores will be assessed at these meetings and any obstacles to progress will be identified. Each Core, including the Administrative Core, will present a status update on any outstanding scientific, administrative or budgetary issues that require immediate attention. These regular meetings will ensure that the program can address problems in a timely manner. They will also serve to make decisions about the resources, priorities, efforts and data access for the whole program, and to resolve potential conflicts. The Internal Data Science Subcommittee will meet at least once a year, with more frequent ad hoc meetings with individual advisory members to review Data Science Core specific issues and report back to the IAC.